Cell-Type Specific Mechanisms of HIV Cardiomyopathy

Project Summary
By 2030, 73% of people with HIV will be ≥ 50 years of age and 78% will have cardiovascular disease. People
with HIV have a 50% increased risk of acute myocardial infarction, a 61% higher risk of heart failure with
reduced ejection fraction and > 4 fold higher rates of sudden cardiac death compared to the general
population. In addition to traditional risk factors, HIV-associated features such as chronic inflammation and
immune dysregulation in the setting of treated HIV infection are strong predictors of cardiovascular disease.
However, studies elucidating the pathogenesis of heart failure in HIV have been largely descriptive and have
thus provided limited insight into the underlying mechanisms of these disease processes. Thus, we propose to
address the pathogenesis of heart failure in people with HIV through investigating the impact of HIV, immune
activation and antiretroviral therapies on the broad range of cell types comprising the human heart. Overall,
the proposed studies will illuminate underlying mechanisms of HIV cardiomyopathy, which may be translated to
the creation of cell-type specific therapies for HIV-related cardiac diseases.

Public health relevance
Project Narrative The overarching goal of the following proposal is to evaluate the underlying mechanisms of heart failure in HIV through a combination of in vivo and in vitro studies that will use novel cardiac tissues, human pluripotent stem cell cardiac disease models and state-of-the art molecular approaches to probe the impact of HIV, immune activation and antiretroviral therapies, on the broad range of cell types comprising the human heart.